Mapping genetic variation in enzyme velocity to growth rate phenotype

PROJECT SUMMARY/ABSTRACT
Over the last thirty years, our capacity to collect genome sequence information has rapidly outpaced our ability
to analyze and interpret it. Despite significant efforts to quantitatively relate genotype to phenotype, we struggle
to predict classic Mendelian traits like height from human genetic data. In apparently simpler organisms, such
as bacteria, we are often unable to predict the effects of even single mutations on growth rate. Indeed,
extending our current knowledge of genotype to the understanding, prediction, and control of global cellular
behaviors (phenotype) remains a central goal of biology. This problem is made complex by three factors: 1) the
mapping between a single gene’s activity and phenotype is non-linear and generally unknown, 2) the mapping
is shaped by epistatic interactions between genes, and 3) the mapping is influenced by environmental factors.
Given knowledge of the parameters governing these three relationships, we then need a strategy to combine
these data into a quantitative model of phenotype. The goal of this grant is to develop exactly such a strategy,
by focusing on an experimentally powerful and well defined instantiation of the genotype to phenotype
problem: how variation in metabolic enzyme activity influences the growth rate of a unicellular organism (E.
coli). We propose a modeling approach in which epistatic relationships between genes and the environment
can all be measured and modeled as continuous, dose-dependent phenomena. To parameterize and test this
model, we will collect over 100,000 growth rate measurements sampling genetic and environmental variation in
folate metabolism, a well-conserved pathway with important roles in human health and disease. These data
will be generated using new methodology developed by my laboratory that combines CRISPR interference
(CRISPRi), next generation sequencing, and continuous culture to quantitatively measure growth rates for
thousands of mutants in parallel under prescribed environmental variation. A small subset of the growth rate
data will be used to mathematically constrain our model (~10-20%), and we will evaluate model performance
on the remainder. We will also assess the capacity of the model to predict growth rates for higher order
combinations of enzyme activity and environmental perturbations not included in the original data set. At
completion, we will have established and tested a complete genotype-phenotype mapping relating changes in
folate pathway enzyme activities to growth rate. This final model will be of immediate relevance for
understanding how variation in folate metabolic enzymes interacts with environmental conditions to influence
resistance to common antibiotics (e.g. trimethoprim). More generally, the modeling framework can be
translated to map genotype-to-phenotype relationships in other biochemical pathways and cell types. This
approach will provide a new strategy for the engineering of biosynthetic pathways, designing personalized
therapies, and inferring the growth rate effects of mutations in higher organisms.

Public health relevance
PROJECT NARRATIVE Genetic mutations in metabolic enzymes play a significant role in human health and disease, yet we lack general, predictive models that can relate these mutations (genotype) to changes in cell growth and behavior (phenotype). The goal of this grant is to construct an experimental and theoretical framework for predicting how metabolic mutations interact with environmental factors to influence cell growth rate, taking E. coli folate metabolism as a model system. This framework will provide a new strategy for engineering metabolic pathways, interpreting disease causing mutations, and designing personalized therapies combining genetic and environmental intervention.